STUDIES OF THE OCULAR COMPLICATIONS OF AIDS

The objectives of this study were 1) to evaluate relative efficacy and safety of Foscarnet and Gancyclovir for the treatment of cytomegalovirus in AIDS; and 2) to evaluate effects of treatment on survival; and 3) to compare relative benefits of immediate treatment vs. deferral of treatment of disease confined to Zones 2 and 3 of the retina.